Cardiovascular Behavioral Medicine Research Training

Abstract
Continuously funded since 1983, the Cardiovascular Behavioral Medicine (CBM) Research Training Program
(HL07560) provides multidisciplinary training in cardiovascular behavioral medicine research to postdoctoral
and predoctoral trainees. The CBM Program trains clinical and translational scientists to conduct
methodologically-rigorous, field-defining, and socially-conscious research at the interface of cardiovascular
physiology, pathophysiology, and behavior to address the public health challenge of cardiovascular disease.
The CBM Program fosters proficiency in four areas: (1) Principles of health behavior and behavior change,
including an advanced theoretical and mechanistic understanding of behaviors impacting the development of
cardiovascular disease; (2) Research methods and statistics, emphasizing design and execution of rigorous,
transparent, and reproducible clinical research as well as advanced statistical techniques; (3) Cardiovascular
physiology and pathophysiology, including the physiologic mechanisms linking psychosocial and behavioral
factors to cardiovascular disease; and (4) Cardiovascular diseases and health disparities, including multilevel
and lifecourse determinants of unequal distributions of cardiovascular health across populations. By providing
training in these areas, the CBM Program aligns closely with the NHLBI programmatic emphases for training
and the NHLBI Strategic Vision for Research to fill an important niche in the NHLBI T32 portfolio. The CBM
Program supports four predoctoral and four postdoctoral trainees annually, with a training duration of 2-3 years
for each trainee. Guided by an individual development plan for each trainee, the program leverages team-
based mentoring, multidisciplinary research training, tailored didactics, and an emphasis on diversity, equity,
and inclusion to equip trainees with the skills and experience needed to attain their career goals. Program
Directors and Associate Directors are a highly experienced team with an extensive history of collaboration to
support successful, coordinated program leadership. The CBM Program also benefits from CBM faculty
members, who are a diverse and accomplished group spanning the Departments of Psychiatry, Psychology,
Medicine, Health and Physical Activity, Bioengineering, and Epidemiology. The CBM program is further
supported by a demonstrated institutional track record of multidisciplinary research and training orientated to
rigor and transparency; diverse course offerings; and excellent research and training resources at the
University of Pittsburgh. With these training goals and resources, the CBM Program is poised for continued
success in meeting NHLBI’s goal of training “a diverse scientific workforce equipped with the research skills,
knowledge, and resources to tackle future heart, lung, blood and sleep challenges.”

Public health relevance
Project Narrative Behavioral, psychological, and social factors contribute to the development of cardiovascular diseases and their unequal distribution across populations. To address the public health burden of cardiovascular diseases, the Strategic Vision of the National Heart, Lung, and Blood Institute has underscored the need to train a diverse workforce of translational scientists who conduct rigorous, interdisciplinary research on the behavioral, psychological, and social factors in cardiovascular disease risk and resilience. Our T32 program has been dedicated to addressing this need for nearly 40 years by providing state-of-the-art training in cardiovascular behavioral medicine research.